GEARBOx - a multisite clinical trial matching tool for children with relapsed or refractory cancer

PROJECT SUMMARY / ABSTRACT
Despite a steady rise in cure rates, cancer remains deadly for many children, especially those with relapsed or
refractory disease. Precision medicine holds great promise for these kids, but matching children to available
clinical trials remains a challenge due a lack of up-to-date information and highly complex eligibility criteria
based on clinical information and genomic and immunophenotype biomarker data. In collaboration with The
Leukemia & Lymphoma Society, the Pediatric Cancer Data Commons (PCDC) team has developed GEARBOx
(Genomic Eligibility Algorithm at Relapse for Better Outcomes), a clinical trial matching tool to allow clinicians
to quickly find potential matches for their patients with relapsed or refractory acute myelogenous leukemia
(AML). We now endeavor to expand GEARBOx to include several more tumor types, including acute
lymphoblastic leukemia, neuroblastoma, rhabdomyosarcoma, Ewing sarcoma, and osteosarcoma. Additionally,
we will augment the often-manual abstraction of eligibility criteria from clinical trials with new automated
methods. The information available to clinicians about trials will be supplemented to include critical data for
how to quickly and efficiently enroll a child on a matched study. Finally, the PCDC team will partner with a
third-party flow cytometry lab (Hematologics) to create ways to automatically pull and incorporate structured
immunophenotype data directly into the GEARBOx tool. These enhancements will greatly enhance the process
of finding appropriate clinical trials for patients and then getting them enrolled, thus improving access to critical
precision therapy for these children.

Public health relevance
PROJECT NARRATIVE Precision medicine holds great hope for children with cancer, but matching kids with available open clinical trials remains a challenge. The Pediatric Cancer Data Commons (PCDC) team at University of Chicago has developed GEARBOx (Genomic Eligibility Algorithm at Relapse for Better Outcomes), a tool to assist clinicians in quickly and efficiently finding a clinical trial for a patient with relapsed or refractory acute myelogenous leukemia (AML). Based on the success of the platform for AML, the PCDC now endeavors to expand GEARBOx to include several more tumor types and to develop better and faster ways to automatically collect and incorporate data into the clinical trial matching algorithm.